EXPANDING THE GENOMIC DATA SCIENCE COMMUNITY NETWORK FOR NHGRI.

Currently, educational opportunities in genomics and data science are primarily limited to resource-rich institutions with access to high-performance computing clusters. This results in an extreme lack of diversity in the genomic data science workforce. By supporting the development of training materials by faculty at institutions with less resources, and increasing dissemination and outreach activities, NHGRI seeks to enable a broader spectrum of undergraduate institutions to have educational and research access to genomic data science through the Genomic Data Science Community Network (GDSCN). GDSCN will empower a broader and more diverse set of undergraduate educational institutions to have access to genomic data science by leveraging the Genomic Data Science Analysis, Visualization, and Informatics Lab-space (AnVIL), a cloud-based data sharing and analysis resource for the genomic scientific community.